Project2: Impact of adipose-tissue derived FGF21 on immunometabolic control of aging

Project 2: Impact of Adipose Tissue-Derived FGF21 on Immune-Metabolic Control of Aging
Abstract
Adipocytes secrete numerous lipid and protein factors with profound effects on systemic energy homeostasis.
One such adipokine that we first identified in the early 1990's, adiponectin (previously referred to as Acrp30),
has garnered significant attention as a potent mediator of insulin sensitivity and cell survival. FGF21 is another
factor that is secreted by a number of cell types (including adipocytes), which has a beneficial effect on
metabolism. During the initial funding period of this Program Project, our group generated a novel mouse model
that overexpresses, in an inducible fashion, physiological levels of FGF21 from adipocytes in the adult mouse.
While comparable levels of constitutive overexpression of FGF21 from the liver do not have an impact on aging
(Mangelsdorf/Kliewer; previous funding cycle), adipocyte-derived FGF21 exerts a profound beneficial impact on
health- and lifespan. This demonstrates that selective manipulation of adipose tissue per se has the potential to
significantly reduce mortality and extend lifespan. The adipocyte-specific FGF21 transgenic animals have
increased energy expenditure, weigh considerably less and exhibit an improvement in all systemic metabolic
parameters examined to date. The mice further display unique immune-metabolic profiles of their adipose tissue
depots, which defy the conventional changes associated with aging. Importantly, all these phenotypic alterations
are achieved without a significant impact on adipose tissue beiging/browning. In addition, we demonstrate that
further improvements on lifespan can be achieved in the absence of adiponectin, suggesting that adiponectin
may exert antagonistic effects on FGF21 action. Moreover, at least some beneficial aspects of FGF21 appear
to be mediated through a lowering of leptin, which leads to central leptin sensitization. As part of the continuation
of our programmatic efforts within this PPG, we will better define the changes that FGF21 introduces in adipose
tissue; primarily focusing on how this mechanistically leads to the dramatic effects on enhanced health- and
lifespan. We will further characterize the FGF21-induced improvements in adipocytes in the context of a whole
body knockout of FGF21, or in the absence of adiponectin and leptin. Alternatively, we will maintain leptin at
baseline levels during FGF21 overexpression. This will allow us to establish whether the metabolic
improvements are still possible without the drop in leptin. Finally, we will subject aged mice that overexpress
FGF21 in adipose tissue to single nuclei sequencing. This will entail using state-of-the-art metabolomics assays,
assessing senescence and turnover of adipocytes and, examining whether mice exhibit an altered exosomal
profile that is released into circulation.
Combined, we hope these efforts will shed additional light on the physiological effects of FGF21. Furthermore,
we hope to establish the unique features and signatures that a fat-pad harbors, which are preserved during the
aging process in order to exert potent beneficial effects on health span and lifespan. These studies will be
performed in close collaboration with Project 1/Dixit and Project 3/Horvath-Schlessinger.

Public health relevance
Relevance Statement Adipose tissue physiology plays a central role in systemic energy homeostasis. We know that FGF21 expression in adipocytes exerts a profound positive effect on health- and lifespan. Here, we want to focus on FGF21-induced changes in adipose tissue that lead to systemic improvements in overall metabolic homeostasis. We will focus on immune-metabolic changes, how they translate into metabolomic and gene expression alterations, with a particular focus on the impact on leptin and adiponectin, and how these adipokines synergize and antagonize FGF21 action. Combined, this will delineate how a fat pad needs to be changed to exert o potently positive impact on health- and lifespan.